Deciphering the Interactome and Functions of Disordered Microproteins

PROJECT SUMMARY
The human genome project was expected to define all protein-coding genes, but many blind spots still persist.
Microproteins are a recently uncovered class of proteins composed of less than 100-150 amino acids encoded
by small open reading frames (smORFs). Previous studies from our group discovered thousands of
unannotated microproteins encoded on transcript regions previously assumed to be non-coding, including on
annotated long non-coding RNAs and 5’- and 3’-untranslated regions (UTRs). While the majority of
microproteins have yet to be functionally characterized, many have been found to regulate fundamental
processes, including DNA repair, RNA metabolism, ER stress, and translation, underscoring their significance
and diverse biological roles. Our long-term vision is to develop strategies for identifying functions for the
remaining thousands of microproteins, which will ultimately expand our understanding of many areas of biology
and potentially reveal new therapeutic approaches for different diseases. In this proposal, our goal is to
leverage the unique biochemical properties of microproteins to rationally screen for which pathways and
processes they participate in. First, microproteins frequently function by interacting with and regulating the
activity of larger proteins and protein complexes. In addition, most microproteins are highly disordered and
enriched for short linear motifs (SLiMs) and other binding motifs that would allow for interactions between their
intrinsically disordered regions (IDRs) and other biomolecules. Based on decades of research on larger
annotated proteins, we know that IDRs are essential to many cellular processes, including cell signaling, RNA
metabolism, and subcellular organization. We also know that many microproteins harbor the same motifs as
annotated proteins involved in these specific processes. We will therefore use a combination of high-
throughput screens and chemical tools to identify protein interaction partners for curated sets of disordered
microproteins that are likely to function in these processes. Then for each validated microprotein interaction
uncovered, we will characterize the microprotein’s role in regulating the activity of the interacting protein(s) and
the particular cellular process it acts on. Altogether, these studies will uncover new functional microproteins
that will expand our understanding of basic biology and provide new insights into health and disease.

Public health relevance
PROJECT NARRATIVE Advances in genomics and proteomics have uncovered thousands of previously unknown small proteins encoded in the human genome, many of which have now been shown to function as regulators of fundamental processes, including genome stability, protein synthesis, and metabolism. This proposal seeks to develop strategies for identifying functions for the vast majority of these novel small proteins that remain uncharacterized. Successful completion of these studies will reveal new mediators of cellular and physiological processes and advance our understanding of human health and disease.